Administrative Supplement for A Multilevel Physical Activity Intervention for South Asian Women and Girls

PROJECT SUMMARY
Women and adolescent girls of South Asian background experience multilevel barriers to physical activity (PA).
The South Asians Active Together (SAATH) trial (R01CA242520) is an ongoing randomized controlled trial that
has enrolled 172 South Asian (SA) American mothers and adolescent daughters to evaluate the effects of a
dyadic physical activity (PA) intervention on moderate to vigorous PA in SA women and girls. The goal of this
administrative supplement to the SAATH trial is to conduct new research to identify and develop replicable
strategies to overcome gender-specific barriers that South Asian women experience to clinical research
participation. Our team has extensive experience with community-engaged recruitment of South Asian
Americans in clinical research; however, SA women and girls remain underrepresented in PA and cancer
prevention research despite persistent health disparities. Even with community-engaged recruitment
approaches, there are strong differences between male and female participants regarding access to
opportunities and multilevel influences on the decision to participate in clinical research. The research
proposed in this supplement targets knowledge gaps about the influence and intersection of gender and
ethnicity on implementation strategies to improve representation of SA women in clinical research.
Specific Aims of this Administrative Supplement are to: 1) Identify how gendered roles, experiences, and
identities influence access, participation, and inclusion as research subjects by performing and analyzing semi-
structured interviews with SA mothers and daughters who did and did not participate in the SAATH trial (n=15
dyads); 2) Develop and evaluate replicable strategies using an intersectional lens and participatory action
model for enhancing access and inclusion of SA women and adolescent girls in PA and cancer prevention
research. This administrative supplement is led by Principal Investigator (PI) Namratha Kandula, MD, MPH and
includes an early stage investigator, Milkie Vu, PhD who will be mentored by the Dr. Kandula to accomplish the
scientific goals of the parent study and supplement. This administrative supplement will address Objective 1.2,
Objective 2.4, and Objective 3.1of the Trans-NIH Strategic Plan for Women's Health Research, which seek to
investigate the influence of sex and gender on disease prevention, presentation, management, and outcomes,
improve the recruitment and retention of women underrepresented in clinical research, and disseminate and
implement evidence-based strategies to improve women's health. Results
new
commitment
from this supplement will provide
knowledge about the intersection of gender and ethnicity to inform replicable strategies to improve
of SA women and adolescents girls for future PA and cancer prevention studies.

Public health relevance
PROJECT NARRATIVE Limited participation of diverse population groups in research threatens health equity. We seek funding to engage South Asian American women and adolescent girls in clinical research, and to co-develop a recruitment and retention model responsive to the gender-related factors that influence women and girls' participation in PA and cancer prevention research. Our results will inform long overdue evidence-based strategies to enhance clinical trial participation and mitigate disparities of underrepresented women and girls.